The Ohio State University Vision Sciences Research Core Program (OSU-VSRCP)

OVERALL MULTI-COMPONENT NEI P30 PROPOSAL abstract
The Ohio State University Vision Sciences Research Core Program (OSU-VSRCP) has established the
expanding vision research scientists across five academic units (i.e., College of Medicine (COM), College of
Optometry (COO), College of Engineering (COE), College of Veterinary Medicine, College of Arts and
Sciences) and newly engaged Nationwide Children’s Hospital. Program Director (PD) Dr. Moroi has
commitment from Deans and Chairs to purchase equipment (i.e., confocal microscope), support data science,
assign scarce space, and increase collaborations. The leadership and scientists are aligned with the NEI PAR-
20-051 ‘to enhance the capabilities of participating NEI-funded investigators and the institution for conducting
vision research.’ Synergy of this community has been established with monthly ViSOR (Vision Sciences OSU
Research) seminars. Synergy between Cores has been defined by the Steering Committee composed of the
PD, Core Directors and Co-directors, who represent Dept. Ophthalmology and Visual Sciences (DOVS), Dept.
Neuroscience, Dept. Biomedical Informatics, Dept. Computer Science (COE), and COO. Synergy between
Cores will coincide with monthly ViSOR meetings. In addition, an Advisory Group will provide guidance twice a
year to the Steering Committee. Based on a survey of 61 scientists, three scientific cores are proposed, which
are re-organized in response to the prior review led by a Director and Co-director, with at least one of the
leaders holding an NEI R01. Core A: Structural and Functional Assessments (SFA) Core A provides
technical expertise and well-maintained state-of-the-art equipment for functional and morphological
assessment of cells and animal models used in vision research. Dr. Moroi arranged the added value of
machine shop services with an agreement with Executive Director Mr. Nate Ames (see letter) of The OSU
Center for Design and Manufacturing Excellence (CDME) to enhance funded research projects. Core B:
Biostatistics, Bioinformatics and Genetic Analysis (BBGA) Core B was re-organized to consolidate
services for traditional statistics and statistical genetics. Users can obtain assistance in research design and
traditional statistics, as well as bioinformatics, pathway analysis, and large-scale genomic data mining that
require advanced computational analytics. Core C: Image Analysis and Data Science (IADS) Core C was re-
organized in response to the growing need for image processing, analysis and data science expertise including
machine learning and artificial intelligence (AI) and development of a Data Commons Architecture for the OSU
vision community. The expected outcome is increased collaboration for successful new proposals with the
shared overarching goal to prevent blindness, restore vision and develop cures for eye diseases.

Public health relevance
NARRATIVE for P30 The purpose of The Ohio State University Vision Sciences Research Core Program (OSU-VSRCP) is to enhance the environment for NEI-funded PIs and other vision science faculty who represent five Colleges: Medicine, Optometry, Veterinary Medicine, Engineering and Arts & Sciences. Three cores are proposed based on a survey of 61 scientists: Core A-Structural and Functional Assessments, Core B-Biostatistics, Bioinformatics and Genetic Analysis, and Core C-Image Analysis and Data Science. The institutional commitment (i.e., support the Program Director includes successful recruitment of vision scientists, space for a new confocal microscope purchase for Core A, and space in the 2023 Interdisciplinary Research Facility) supports our common goal to prevent blindness, restore vision and develop cures for eye diseases.